Repurposing antimalarials for the treatment of NTM infections

Abstract
The prevalence of pulmonary nontuberculous mycobacterial (NTM) infections caused by Mycobacterium
abscessus complex (MABSC) and Mycobacterium avium complex (MAC) species is increasing worldwide and
poses a particular threat to susceptible individuals with structural or functional lung conditions such as cystic
fibrosis, chronic obstructive pulmonary disease and bronchiectasis. The intrinsic recalcitrance of these
pathogens to chemotherapeutic treatments and alarming treatment failure rates place a high priority on the
development of more effective treatment approaches.
The ability of MABSC and MAC to persist intracellularly and extracellularly within granulomatous lesions in a
non-replicating state is likely to contribute to the drug tolerance of these microorganisms and to treatment failure
in chronically-infected individuals. Further compounding this problem is the ability of MABSC and MAC to form
what appears to be genetically programmed biofilms during human pulmonary infections. A common stress faced
by intra- and extracellular NTM inside activated immune cells, in avascular necrotic and caseous regions of
granulomas, and within microaggregates or biofilms is the inhibition of aerobic respiration caused by O2 depletion
or exposure to nitric oxide (NO) and carbon monoxide. M. tuberculosis (Mtb) is known to survive this stress by
inducing a regulon of ~50 genes that drives the entry of the bacterium in a non-replicating state while adapting
its metabolism to maintain energy levels and a redox balance compatible with survival in the absence of
respiration. Accordingly, inhibitors of the regulator which controls the expression of this regulon are actively being
sought for their potential to shorten tuberculosis treatment and lower relapse rates when used in combination
with standard-of-care antibiotics.
Our recent studies indicate that the orthologous regulators of MABSC and MAC play a similar function as in Mtb.
Genetic and pharmacological disruption of this regulator in MABSC led to inhibition of biofilm formation in addition
to decreasing bacterial viability and reversing drug tolerance under hypoxia. Most importantly, two inhibitors of
this regulator in MABSC which we identified showed significant bactericidal activity in MABSC-infected mice in
addition to potentiating the activity of standard-of-care antibiotics used in combination. Since these two inhibitors
are either clinically-used or in phase II clinical trial, they offer repurposing opportunities that could be a short
route to the clinic.
These exciting findings stimulated the submission of this grant application in which we propose to thoroughly
decipher the mechanisms underlying the therapeutic and adjunct therapeutic benefits of these inhibitors in
MABSC (Aim 1) and to determine whether the same therapeutic strategy may be applied to MAC (Aim 2).

Public health relevance
Project Narrative Building on our recent discovery that antimalarial drugs display potent therapeutic and adjunct therapeutic efficacy against Mycobacterium abscessus infections, this research project proposes to thoroughly investigate the mechanisms underlying the therapeutic benefits of these drugs and to extend their use to the treatment of Mycobacterium avium infections. Success in this approach could be a short route to the clinic.